Evaluating a Novel Method to Determine the rTMS Dose Needed for Treating Depression After Spinal Cord Injury

Depression is a leading cause of disability worldwide and is one of the most prevalent neuropsychiatric disorders
following spinal cord injury (SCI). The burden of depression post-SCI is significant, as it is associated with higher
cost, lower quality of life, and shorter survival time. Treating depression can be complicated, but it is vital.
Repetitive transcranial magnetic stimulation (rTMS), a type of non-invasive brain stimulation, is an FDA-approved
treatment option for depression that is utilized throughout the Veterans Affairs (VA) health system. However, no
published studies have examined the effectiveness of rTMS for depression post-SCI. The updated Clinical
Practice Guidelines for Spinal Cord Medicine for the Management of Mental Health Disorders (2020) by the
Paralyzed Veterans of America recommends explicitly that future research examines rTMS in the SCI population.
The critical challenge of administering rTMS for depression post-SCI is dosing. Currently, the resting motor
threshold, a motor response of the right abductor pollicis brevis, is used to dose rTMS. Over half of the SCI
population has incomplete or complete tetraplegia, indicating some degree of upper extremity [(UE)] impairment.
Thus, if using current rTMS dosing parameters, it is plausible to conclude that over half the SCI population could
be excluded from receiving rTMS for depression or may receive an improper dose, impacting the intervention's
safety and effectiveness. [This study specifically addresses current limitations in treating depression post-
SCI using rTMS and will: (1) identify the target electric-field (e-field) for rTMS; (2) evaluate a novel
method, reverse-calculation e-field modeling, to determine the rTMS dose to treat depression in
individuals with SCI; (3) conduct a pilot clinical trial using reverse-calculation e-field modeling to dose
rTMS for depression post-SCI; (4) provide the appropriate training environment for the applicant to
develop into an independent VA researcher; and (5) generate the necessary pilot data to support a future
VA Merit Award application.] E-field modeling is a computational model that accounts for the TMS coil type,
circuitry and placement, individual anatomy obtained through T1 and T2- weighted magnetic resonance images,
and conductivity variance between tissue types. [First, using existing trial data, e-field modeling will be used to
determine the target e-field dose for treating depression with rTMS.] Next, twenty-four individuals with SCI and
depression will be randomized to receive either 6-weeks of rTMS treatment dosed using reverse-calculation e-
field modeling (n=18) or sham treatment (n=6). We will examine the between-group effects of treatment on
depressive symptoms using the Hamilton Rating Scale for Depression. The dose identified by reverse-calculation
e-field modeling will be used in combination with FDA-approved parameters: 3,000 pulses/session at 10 Hz, 5
days/week for 6 weeks. Study outcomes will include changes in depressive symptoms, quality of life [(QOL)],
and participation. During the award period, the applicant will capitalize on resources available through the Ralph
H. Johnson VA Medical Center and its affiliated academic institution, Medical University of South Carolina. One
primary example is the National Center for Neuromodulation for Rehabilitation (NIH P2 CHD086844). By utilizing
these resources and hands-on training from renowned local experts, the applicant aims to develop the requisite
skills and understanding of data acquisition, analysis, and interpretation of neurobiological variables, imaging,
and e-field modeling. The overall goal of this CDA-2 application is to expose the candidate to a rich local
environment for SCI recovery research, providing the foundation for developing into an independent VA
researcher studying the effects of and viable treatment options for depression post-SCI to improve the
lives and rehabilitation outcomes of Veterans. The proposed training plan will enhance the candidate's
understanding of neuromodulation, neuropsychiatric disorders, and the design and delivery of neurorehabilitation
trials. The data generated will inform the development of additional interventions focused on neuromodulation to
improve function and QOL for individuals following SCI and other patient populations with UE motor impairment.

Public health relevance
Depression is a leading cause of disability worldwide and is more commonly seen in individual’s post-spinal cord injury (SCI) than in the general population. Depression post-SCI impacts an individuals’ quality of life and recovery. It has been reported that among Veterans with an SCI, those without depression live longer than those with depression. Thus, depression must be treated appropriately. Repetitive transcranial magnetic stimulation (rTMS) is an FDA-approved treatment for depression, but dosing is based on a motor response in the thumb. Over half of individuals with SCI have some degree of arm or hand impairment, so these individuals might not be eligible for rTMS, or they may receive the wrong dose. [This study proposes secondary data analysis of a completed trial and a clinical trial in individuals with depression post-SCI to assess the anti-depressant effect of a novel technique to dose rTMS that does not require a motor response.] By gaining a better understanding of the application of rTMS for depression post-SCI, we aim to advance the rehabilitative care of Veterans.